Forecasting Trachoma Control - Diversity Supplement

PROJECT SUMMARY/ABSTRACT
Annual mass azithromycin distribution dramatically reduces the prevalence strains of Chlamydia trachomatis
that lead to blindness. Current World Health Organization guidelines indicate that annual mass azithromycin
distribution should be continued until district-level prevalence of the clinical sign of trachoma, trachomatous
inflammation-follicular (TF), drops below 5%. However, TF doesn’t correlate well with true prevalence and there
is no gold standard to detect this. Here, we propose that a Hidden Markov Model 1) will identify the true
prevalence in hypo-endemic areas that can be used as a signal that the mass azithromycin protocol was
successful and an indicator to stop antibiotics and 2) identify hyperendemic areas that the protocol has not been
successful to change the treatment regimen. We anticipate that results will provide evidence to support altering
the modification of current interventions for trachoma.

Public health relevance
PROJECT NARRATIVE The WHO currently recommends annual mass azithromycin distribution in trachoma-endemic areas until the district-level prevalence of trachomatous inflammation-follicular (TF) drops below 5%. Since there is no true gold standard test to assess the prevalence of active disease, we will use a model which assumes a true, but latent or hidden state of infection. We anticipate that the results of this study will provide will show modestly improved precision of detecting the true state of trachomatis infection in a hypoendemic and hyperendemic communities.